Molecular Mechanisms of Bacterial Stress Response Relevant to Host-Microbe Interactions

! #
.;8 <AG8E9468 58GJ88A 546G8E<4 4A7 G;8 <@@HA8 FLFG8@ <F 45FB?HG8?L 9HA74@8AG4? GB ;H@4A ;84?G; .;8 %52$'
/21* 7(50 2%-(&7,9( B9 G;<F E8F84E6; CEB=86G <F GB HA78EFG4A7 G;<F <AG8E9468
.;8 <AA4G8 <@@HA8 FLFG8@ 6BAGEB?F 546G8E<4? 6B?BA<M4G<BA B9 8C<G;8?<4? FHE9468F J<G; 4 I4E<8GL B9 ;8@8 C8EBK<74F8
8AML@8F G;4G :8A8E4G8 CBJ8E9H? 4AG<@<6EB5<4? BK<74AGF <A6?H7<A: ;LCB6;?BEBHF 46<7 ") ? G;8 46G<I8 <A:E87<8AG
<A ;BHF8;B?7 5?846; ;LCB5EB@BHF 46<7 4A7 ;LCBG;<B6L4A<G8 <998E8AG ><A7F B9 546G8E<4 4E8 45?8 GB @BHAG 4
I4E<8GL B9 7898AF8F 4:4<AFG G;8F8 GBK<6 6;8@<64?F J;<6; 78G8E@<A8F G;8<E 45<?<GL GB FHEI<I8 BA ;BFG 8C<G;8?<4?
FHE9468F BE C4G;B:8A<6 546G8E<4 G;8F8 7898AF<I8 C4G;J4LF 4E8 <@CBEG4AG 9BE G;8<E 45<?<GL GB 64HF8 7<F84F8
J;<?8 9BE ;84?G; CEB@BG<A: CEB5<BG<6F 4A7 6B@@8AF4? @8@58EF B9 G;8 @<6EB5<B@8 G;8L 4E8 78G8E@<A4AGF B9 ;BJ
J8?? G;BF8 FC86<8F 4E8 45?8 GB 6B?BA<M8 G;8<E ;BFGF 4A7 FHEI<I8 7HE<A: C8E<B7F B9 <A9?4@@4G<BA
#A E8FCBAF8 GB ") ? % $ " 4 CEB<A9?4@@4GBEL @8@58E B9 G;8 :HG @<6EB5<BG4 4A7 BG;8E 546G8E<4
FLAG;8F<M8 ?4E:8 4@BHAGF B9 <ABE:4A<6 CB?LC;BFC;4G8 CB?L* 4 HA<I8EF4??L 6BAF8EI87 5<BCB?L@8E B9 C;BFC;4G8
HC GB HA<GF ?BA: *B?L* 6BAGE<5HG8F GB 546G8E<4? FHEI<I4? 5L 4@BA: BG;8E 9HA6G<BAF FG45<?<M<A: 74@4:87
CEBG8<AF 4A7 E8:H?4G<A: CEBG84F8 46G<I<GL 4A7 6;EB@BFB@8 E8C?<64G<BA "BJ8I8E I8EL ?<GG?8 <F >ABJA 45BHG ;BJ
G;8 CEB7H6G<BA B9 G;<F CEBG86G<I8 6B@CBHA7 <F E8:H?4G87 <A E8FCBAF8 8<G;8E GB ") ? BE GB BG;8E FGE8FF 6BA7<G<BAF
.;8 @BFG ;<:;?L HCE8:H?4G87 :8A8F <A ") ? 8KCBF87 " 4E8 G;BF8 58?BA:<A: GB G;8 $ BC8EBA 6BAGEB??87
5L G;8 ") ? F8AF<A: GE4AF6E<CG<BA 946GBE ,6?, ,6? ;4F 6BCC8E ## E87H6G4F8 46G<I<GL CEBG86GF " 4:4<AFG
G;8 6B@5<A4G<BA B9 ") ? 4A7 <AGE468??H?4E 6BCC8E GBK<6<GL 4A7 <F 6BAF8EI87 4@BA: 4 I8EL J<78 E4A:8 B9 ;BFG
6B?BA<M<A: 546G8E<4 <A6?H7<A: 5BG; ;84?G; 4A7 7<F84F8 4FFB6<4G87 FC86<8F .;8 CE86<F8 @86;4A<F@ 5L J;<6;
,6? CEBG86GF 546G8E<4 4:4<AFG G;8F8 FGE8FF8F E8@4<AF HA6?84E ;BJ8I8E 4F 7B G;8 9HA6G<BAF B9 G;8 ,6? 4A7
,6? CEBG8<AF J;<6; 4E8 6BAF8EI87 BA?L <A CEB<A9?4@@4GBEL 8AG8EB546G8E<4
.;8E89BE8 G;8 .(< *$36 ,1 81'(567$1',1* 477E8FF87 <A G;<F E8F84E6; CEBCBF4? 4E8 G;8 9B??BJ<A:
2: '2 %$&7(5,$ 5(*8/$7( 7+( 6<17+(6,6 2) ,125*$1,& 32/<3+263+$7(
2: '2 7+( &/ 3527(,16 3527(&7 +267 $662&,$7(' %$&7(5,$ $*$,167 2;,'$7,9( 675(66
2: '2 7+(6( 3$7+:$<6 $))(&7 +267 0,&52%( ,17(5$&7,216
18 J<?? 477E8FF G;8F8 DH8FG<BAF HF<A: 4 I4?<74G87 6B??45BE4G<I8 E8F84E6; FGE4G8:L G;4G HF8F :8A8G<6 4A7 GE4A
F6E<CGB@<6 4A4?LF<F B9 FC86<9<6 FGE8FF F8AF<A: E8:H?4GBEF GB <78AG<9L E8?8I4AG :8A8F 4A7 C4G;J4LF <A ;BFG 4FFB6<
4G87 546G8E<4 9B??BJ87 5L 6B@5<A87 :8A8G<6 5<B<A9BE@4G<6 4A7 5<B6;8@<64? 4CCEB46;8F GB 8FG45?<F; 4 @86;4
A<FG<6 HA78EFG4A7<A: B9 G;8 E8?8I4AG @<6EB5<4? C;LF<B?B:L

Public health relevance
PROJECT NARRATIVE Bacteria have major impacts on human wellness, both as the causes of acute infections and as members of the health-promoting microbiome. The research described in this proposal is aimed at understanding how bacteria sense and respond to antimicrobial oxidants produced by innate immune cells at the interface between microbes and host organisms. We expect the results of these studies to contribute to fundamental knowledge about how both health- and disease-associated bacteria interact with the immune system, which, in the long term, will facilitate the development of new strategies to manipulate those interactions to promote human health.